Exosome Signatures of Kidney Cancer Response to Immune Checkpoint Inhibitor

Project Summary
Combined immune checkpoint inhibitor therapy with nivolumab plus ipilimumab has become a standard first-line
treatment for metastatic renal cell carcinoma (RCC). Unfortunately, information regarding whether patients are
responding to this treatment regimen is not known until tumor diameters are measured on a computed
tomography (CT) scan 2-3 months after starting therapy. This is because changes in tumor size typically cannot
be reliably measured before this time frame. Patients for whom therapy is ineffective endure treatment side
effects without benefit. Therefore, early biomarkers for therapeutic response are needed so that effective and
ineffective treatment can be distinguished earlier than current standard of care and patients who do not derive
benefit from this combination therapy can move on quicker to a potentially more effective treatment.
Blood and urine exosomes are a prime candidate for serving as such a biomarker. The complex mechanisms of
action of these drugs involve tumor cells, epithelial cells, immune cells, and other host factors. All these cells
release exosomes into the blood stream, which contain protein and RNA derived from these cell types. Therefore,
we hypothesize that early molecular effects in these cell types that lead to changes in tumor size on a 3-month
CT scan can be measured in plasma proteins and/or exosomal proteins and RNA, specifically changes in KIM-
1, PD-L1, and exosomal micro-RNAs. Thus, exosomes may carry an early biomarker for therapeutic response
that can be measured by protein analysis and transcriptomic profiling of exosomes isolated from blood and urine.
In this pilot study, we will sequence exosomal RNA from the blood and urine of 50 patients with RCC at 3 time
points: at treatment baseline and 3 and 6 weeks after initiating therapy with nivolumab and ipilimumab. We will
1) define for each analyte an exosome signature of response by determining the subset of exosomal transcripts
that is differentially expressed on therapy compared to baseline and that correlates with the relative change in
tumor burden; and 2) determine how early on treatment such a predictive signature can be feasibly detected
(week 3 vs. week 6); and 3) whether blood exosomes alone, urine exosomes alone, or both in combination allow
for the most accurate prediction of response.
We will use this information to select the on-therapy time point and sampling strategy for validating this candidate
predictive biomarker for response in a follow-up study.

Public health relevance
Project Narrative In patients with metastatic kidney cancer (renal cell carcinoma) treated with immunotherapy nivolumab plus ipilimumab, we seek to determine if blood and urine exosomes (small vesicles that are shed from cells in the body, including tumor cells) measured with RNA sequencing before and at 3 weeks and 6 weeks after initiating therapy can predict response to therapy measured by standard-of-care computed tomography scans after 3 months of therapy.